Cooperative Agreement to Support the Joint Institute for Food Safety and Applied Nutrition (JIFSAN)

Project Summary Abstract
The Joint Institute for Food Safety & Applied Nutrition (JIFSAN) at the University of Maryland, College
Park was established by the University and the U.S. Food & Drug Administration (FDA) in 1996 to
advance sound strategies that improve public health, food safety, and applied nutrition using risk
analysis principles through cooperative research, education and outreach programs. The JIFSAN's
programs support the Food Safety Modernization Act that emphasizes the concept of preventing food
safety-related problems before they occur and enhance FDA's efforts to partner with other nations to
improve U.S. and worldwide health. JIFSAN's vision is to be an internationally recognized source of
scientific information and trainings on food safety, applied nutrition and animal health. This renewal is
to obtain funding for an additional five years (21-25) of the FDA Cooperative Agreement. This
proposal includes administrative, research and programmatic support to 1) establish multi-
institutional, multidisciplinary applied research projects to address complex food/feed safety and
public health issues with products that FDA regulates; 2) continue the development of mechanisms
for the exchange of technical information and scientific concepts between FDA and other sectors of
the international and domestic community, through workshops, short courses and symposium, and
online resources that focus on existing and emerging complex food/feed safety and public health
issues; 3) continue the development and refinement of programs based on the application of the
principles of risk analysis to address food/feed defense and safety issues; 4) continue the design and
improvement of domestic and international collaborations, which foster greater implementation of
effective food safety practices; and 5) continue developing innovative education and outreach
programs that will provide opportunities to leverage resources among various sectors of stakeholders
to address complex safety issues associated with an increasingly diverse global food/feed supply.

Public health relevance
Project Narrative As one of four Centers of Excellence (COEs) of FDA's Center for Food Safety and Applied Nutrition, JIFSAN conducts various research and outreach activities in food safety and applied nutrition to help ensure that regulatory decisions have a sound science footing and that the best methods and tools are available to advance food and cosmetics safety. The JIFSAN's programs support the Food Safety Modernization Act that emphasizes the concept of preventing food safety-related problems before they occur and enhance FDA's efforts to partner with other nations to improve U.S. and worldwide health.